Autoantibodies define scleroderma subgroups with distinct relationships to cancer

PROJECT SUMMARY
Emerging data highlight previously unappreciated connections between cancer and scleroderma (SSc). Using
autoantibodies as probes to identify clinically and biologically relevant SSc subgroups, we have shown that
patients with anti-RNA polymerase III (POLR3), anti-RNPC3 or (monospecific) anti-Ro52 antibodies are more
likely to have a cancer emerge close to the time of scleroderma onset.1-6 In contrast, antibodies against
centromere, U1RNP, or Th/To proteins appear to define a subset of SSc patients with a lower cancer risk.3, 6, 7
Interestingly, patients with anti-POLR3 or anti-Ro52 who are positive for additional autoantibodies, including anti-
RPA194, anti-Th/To and anti-U1RNP, do not have increased cancer risk suggesting that increased breadth of
the immune response may be cancer protective.6-8 These data strongly suggest that SSc-specific
autoantibodies may be powerful tools for cancer risk stratification. It remains unknown whether (i) cancer
is a driver for the development of autoimmunity more broadly in SSc, (ii) diversified immune responses are
exerting potent anti-tumor pressure, (iii) autoantibody strength and breadth are predictive of incident cancer
diagnosis, and (iv) cancer emergence and elimination influences changes in SSc clinical outcomes and immune
responses. The proposed studies will use prospective and retrospectively collected data and
biospecimens from two well-characterized SSc cohorts to study the key relationships between
malignancy, the immune response and clinical expression of SSc. We will accomplish this through the
following specific aims: Aim 1 will test whether novel tumor markers, genetics, SSc autoantibody and clinical
features associate with incident cancer diagnoses in two large SSc cohorts. These data will provide a critical
foundation for the development of clinically actionable, targeted and evidence-based approaches for cancer
detection in patients with new onset SSc. Aim 2 will define whether cancer emergence or elimination influences
scleroderma clinical outcomes. We will address whether cancer remission associates with clinical improvement
in SSc and qualitative or quantitative changes in the autoantibody responses across this transition. In a
prospective study, we will test whether subclinical malignancy assessed by liquid biopsy shapes the immune
response and SSc disease process. Among those with a new clinical cancer diagnosis, we will assess whether
the mutational signature in the cancer matches that observed in circulating tumor DNA. These data, rigorously
generated in two of the largest SSc cohorts in the US, are likely to provide important insights with direct
relevance to management and therapy of SSc, while also illuminating the mechanisms operating at the
interface between cancer, anti-tumor immunity and autoimmunity in SSc. This approach is also relevant
to other autoimmune rheumatic diseases in which cancer and rheumatic disease onset are temporally
linked.

Public health relevance
Project Narrative There is growing evidence that distinct subgroups of scleroderma patients have an increased risk of cancer, and that unique scleroderma immune responses, alone or in combination, associate with cancer protection. It remains unknown whether cancer drives the autoimmune response more broadly in scleroderma, whether diversified immune responses exert potent anti-tumor pressure, and whether cancer treatment is effective scleroderma therapy. To address these knowledge gaps, this proposal will (i) study the value of innovative cancer and immune response measurements in identifying patients with incident cancer diagnosis, and (ii) investigate the relationships between malignancy, the immune response, and scleroderma disease activity in two of the largest scleroderma cohorts in the US.